Senior Leadership

The Senior Leadership of the USC Norris Comprehensive Cancer Center is comprised of the Director and six Associate Directors for Translational Research, Basic Research, Clinical Research, Cancer Cause and Prevention Research, Pediatric Oncology, and Administration and Education.

Public health relevance
The Cancer Center facilitates the discovery and development of more effective approaches to cancer prevention, diagnosis, and treatment, as well as deliver medical advances to patients and their families, educate health care professionals and the public, and reach out to underserved populations.